The Balance Between Stability and Function in Naturally Occurring and Engineered Proteins

Project Summary/Abstract
This Administrative Supplement to parent grant 1R15GM134439 requests funds to compensate for time and
productivity lost during the maternity leave following the birth of the PI’s first child at the beginning of the parent
grant period. These funds will allow the PI to put concerted effort towards these projects in the form of
additional undergraduate students and additional hours for the research technician during the final months of
the grant period.
Rational protein design is an exciting avenue for developing new vaccines, diagnostics, and therapeutics for
human diseases. The ability to intentionally design thermostable proteins will allow expansion of this technique
to applications that are subject to harsh storage or transport conditions. Nonfunctional, de novo designed
proteins tend to be unusually stable, but there has been minimal investigation as to the structural and dynamic
basis for thermostability in these proteins. It is additionally unclear whether protein designers are exploiting the
same thermostabilization strategies in their designs as nature does in the proteins of organisms that evolved to
live at high temperatures. We aim to determine the structural and dynamic bases for thermostability in
designed proteins and compare them with thermostabilization strategies observed in thermophilic proteins.
Further, we aim to determine whether the thermostabilization strategies employed by protein designers are
compatible with function. We hypothesize that protein designers have employed thermostabilization strategies
that are not common in nature, and these strategies may hinder designed proteins’ abilities to function.
The Engrailed homeodomain is a three-helix bundle transcription factor from D. melanogaster, and its
structure, native state dynamics, and folding pathway have been well characterized. It served as the template
in two protein design studies, both of which produced thermostable proteins. First, we will identify the
thermostabilization mechanisms in these designed proteins and compare the mechanisms with those we
observe in a homologous, thermophilic DNA-binding protein. Second, we will determine whether the
thermostabilization strategies observed in the designed proteins are compatible with DNA-binding function.
Finally, we will identify families of more complex proteins containing a designed thermostable, natural
thermostable, and a thermolabile member and compare their thermostabilization strategies with those
observed in the model, three-helix bundle family. These aims will be accomplished using a complementary set
of computational and biophysical techniques. Molecular dynamics simulations of these proteins performed at
various temperatures have generated predictions that will be tested experimentally using DNA-binding and
equilibrium unfolding assays. The results of this study will provide knowledge of how to deploy
thermostabilization strategies that are compatible with function, which will be critical to protein designers’
success in developing protein-based vaccines, diagnostics, or therapies subjected to harsh storage conditions.

Public health relevance
Project Narrative Understanding the structural basis for thermostability in designed and naturally occurring proteins will enable the rational design of intentionally thermostable proteins that perform a desired function. Designed, thermostable proteins have the potential to be used in vaccines, diagnostics, and treatments that are subjected to harsh environments during storage or transport. In this project, we will determine the balance between thermostability and function in a simple model set of proteins, and we will investigate the structural and dynamic basis of thermostability in protein families that are more complex.